Career Enhancement Program

CAREER ENHANCEMENT PROGRAM (CEP): SUMMARY
Despite the tremendous recent advances in lung cancer research, it remains the leading cause of cancer death
worldwide. Ensuring that there is a robust pipeline of talented investigators pursuing lung cancer research is
essential to establish future discoveries and further improve lung cancer outcomes. The availability of appealing
career opportunities in industry makes the recruitment and retention of talented investigators in academia
challenging. The Career Enhancement Program (CEP) of the Yale SPORE in Lung Cancer (YSILC) is designed
to address this problem by providing funding, mentoring and support for investigators interested in pursuing a
career in lung cancer research. The goal of the CEP is to train a new generation of investigators committed to
translational research in lung cancer. The CEP has substantial institutional commitment, both in terms of funding
and infrastructure. Potential CEP candidates include promising junior faculty who are interested in establishing
their careers in translational lung cancer research and/or established investigators whose previous research has
been in other areas and who would like to transition into lung cancer focused research. Awardees will be paired
with mentors who are more established lung cancer investigators with a documented record of successful
mentoring. In this way, the YSILC will stimulate the development of the next generation of lung cancer scientists,
to tackle the most challenging issues in lung cancer research.